Parental Alcohlism & Child Environmental Risk

DESCRIPTION (provided by applicant): Inferences about the environmental influences of parental alcoholism on risk of childhood disorders such as Attention Deficit Hyperactivity Disorder or Conduct Disorder, or Depression, which in turn predict increased offspring risk of alcohol use disorders and associated high-risk behaviors (e.g.: early onset of alcohol use), have been hindered by a failure to recognize (i) the confounding of genetic effects, and genotype x shared environment interaction effects in the twin design, and (ii) the selection for high risk genetic backgrounds, but reduced environmental risk exposures, in adoption study designs. As an alternative, we propose a children-of twins study, that builds upon our prior studies of a cohort of young adult Australian twins characterized by a history of heavy drinking and high rates of alcohol problems, in women as well as men. Comparison of outcomes in children exposed to both high genetic and high environmental risk (twin father is alcohol dependent [AD], or twin mother is AD or alcohol abuser [AB]: 'alcoholic' [ALC]), children exposed to reduced environmental risk but varying degrees of genetic risk (twin parent is unaffected, but parent's MZ, DZ female, or DZ male cotwin is alcoholic: 'high risk'), and children from control families (twin parent, and parent's cotwin, both unaffected), will enable us to identify high risk environmental exposures associated with parental alcoholism that are predictive of offspring outcomes, with statistical control for genetic transmission of risk. Intake, 2-yr and in some cases 4-yr follow-up interviews will be conducted with the children's parents (a projected N=1900 parents reporting about 3350 offspring aged 7 yrs and older, as well as about own and partner's history of alcohol use and comorbid disorders) and with male and female offspring aged 11 yrs and older (N=2260), and will be supplemented by intake interviews with co-parents of these offspring (N=1300). Hypotheses will be tested about the pathways by which alcoholism in the parental generation via genetic transmission and/or increased high-risk environmental exposures, is associated with increased risk of psychopathology and other high-risk outcomes in offspring, taking into consideration pre-conception factors I (mate selection), pre-natal risk-factors (maternal smoking and drinking), and post-natal factors (both factors I associated with the presence of an alcoholic parent in the home, and factors such as socioeconomic disadvantage I associated with parental absence or parental past history of ALC).